Neurolinguistic development in 4 to 8 year-old late talkers with language delay

PROJECT SUMMARY
Late talking is associated with negative academic and socio-emotional outcomes. Despite this, behavioral
measures are relatively poor at predicting who will end up having developmental language disorder. Moreover,
not much is known about either the typical neurocognitive changes associated with language development or
the brain basis of delayed language during preschool, as there have been only three retrospective studies. This
project uses well-controlled functional neuroimaging paradigms tapping into receptive language skills and
structural imaging of white matter connectivity, as well as an extensive behavioral battery that measures well-
established deficits in phonology, semantics and morphology. Four-year-olds, oversampled for late talking, are
longitudinally followed when they are 6- and 8-years-old. The first aim determines the sensitivity of the dorsal
and ventral pathways to phonological and semantic skills, respectively, motivated by the predictions of the Dual
Stream Theory. The second and third aim determine the strength of the directional effects of these pathways on
each other, and whether these effects differ depending on age. The fourth aim determines the effect of these
pathways on the behavioral development of morphology. Our finding that phonological processing drives the
development of semantic and morphological processing would be consistent with Phonological Theory, that
semantic processing drives the acquisition of phonological and morphological processing would be consistent
with Semantic Theory, or that there are interactive effects would be consistent with Bidirectional Theory. Using
a state-of-the-art analytical approach justified by tailored power analyses, we expect to find evidence supporting
a model in which early phonological processing drives semantic change and later semantic processing drives
morphological change. Although we have theoretically motivated planned comparisons, exploratory analyses
will also be conducted to support future work. The scientific rigor of the project is supported by our extensive
published research examining phonological and semantic specialization of the brain in kindergarteners into
elementary school. The feasibility of the project is supported by our encouraging pilot behavioral and
neuroimaging data in 4-year-olds on the exact paradigms to be used in this project. Although we take a
dimensional approach to test our model, as research shows that language ability is on a continuum, we also
perform exploratory categorical analyses comparing late talkers to typical children. Research is inconclusive with
regards to the role of screening of language delay to inform decisions of early intervention. We hope that a more
basic mechanistic understanding of the dynamics of language development will allow for the formulation of
predictive biomarkers to be used in screening for intervention. We are committed to open science, and plan to
pre-register our work, and share our analytical code and data.

Public health relevance
PROJECT NARRATIVE This project will be the first to longitudinally examine the brain basis of preschool language development in typical children and late talkers. Children with language delay are at risk for a host of later academic and socio- emotional problems, but we do not have good predictive models of who will have negative outcomes. Elucidating the drivers of development has implications for the screening of language delay with objective biomarkers to mechanistically inform early intervention.